Gene Network Identification and Integration (GNetii) Approach to Understanding the Biology Underlying HIV and Drug Abuse.

PROJECT SUMMARY/ABSTRACT
Not Applicable.

Public health relevance
PROJECT NARRATIVE Not Applicable.